Appalachian Career Training in Oncology (ACTION) Program

PROJECT SUMMARY/ABSTRACT
The rural Appalachian Kentucky region has the highest cancer incidence and mortality rates in the United
States, and it is also one of the most economically disadvantaged, medically underserved, and poorly educated
regions of the country. These disparities reveal a critical need for educational and scientific workforce
preparedness intervention strategies targeted to this population. Through a Continuing Umbrella of Research
Experiences (CURE) supplement in 2016, the research, clinical care, educational, and outreach strengths of the
University of Kentucky’s Markey Cancer Center were leveraged to create the Appalachian Career Training In
ONcology (ACTION) Program, which has been funded as a Youth Enjoy Science education intervention since
2018. In this renewal, each year the ACTION Program will immerse 20 underrepresented high school and 20
undergraduate students from Appalachian Kentucky in mentored cancer research, cancer care observation
experiences, cancer education and career development activities, as well as hands-on community outreach
activities. The goal of the program is to enhance the diversity of the biomedical workforce by preparing
underrepresented Appalachian Kentucky high school and undergraduate students for biomedical careers, while
also increasing the community’s understanding of cancer, thereby addressing the cancer and education
disparities in Appalachian Kentucky and beyond. Impacts of the program will include: 1) supporting students’
matriculation into post-secondary, professional, and/or graduate biomedical degree programs; 2) instilling in
students a lifelong commitment to research, education/outreach, and/or health care careers focused on the
cancer burden and unique challenges in Appalachian Kentucky and beyond; and 3) enhancing the Appalachian
Kentucky community’s understanding of cancer, cancer research, and clinical care, and linking these facets to
the benefits of science education. The overarching goal and the program impacts will be accomplished through
three Specific Aims: 1) to develop students’ cancer research knowledge and skills through cross-disciplinary
faculty- and peer-mentored research training experiences; 2) to enhance students’ career preparation by
providing cancer education and career development curriculum through faculty- and peer-led courses,
workshops, seminars, and career coaching and mentoring; and 3) to increase the understanding of the research
and clinical aspects of cancer and the importance of science education among students and teachers,
parents/caregivers and families of ACTION students, and general community members through impactful
outreach activities in students’ communities. New features of the program will include virtual research education
experiences that complement hands-on research and education activities, a multi-institutional virtual outreach
program, and a cancer curriculum outreach program for middle and high school students and teachers. With
significant momentum achieved since its creation, the ACTION Program will continue having a transformational
impact on Appalachian Kentucky students, their families, and their communities.

Public health relevance
PROJECT NARRATIVE The renewal of the University of Kentucky Markey Cancer Center’s Appalachian Career Training In ONcology (ACTION) Program will continue a culturally centered cancer education and training opportunity for students from rural, disease-burdened, low socioeconomic, and low education-attainment Appalachian Kentucky communities. The program will enhance the diversity of the biomedical workforce by preparing underrepresented Appalachian Kentucky high school and undergraduate students for biomedical careers. ACTION will also increase the community’s understanding of cancer, thereby addressing the cancer and education disparities in Appalachian Kentucky and beyond.